Genetic Epidemiology of Causal Variants across the Life Course Phase II (CALiCo I

Provide a summary of the proposed activity suitable for dissemination to the public. It should be a self-contained description of the project and should contain a statement of objectives and methods to be employed. It should be informative to other persons working in the same or related fields and insofar as possible understandable to a scientifically or technically literate lay reader. This abstract must not include any proprietary or confidential information. This section must be no longer than 30 lines of text. 2.

Public health relevance
Using no more than two or three sentences, describe the relevance of this research to public health. In this section, be succinct and use plain language that can be understood by a general, lay audience. Best regards, Zephaun Harvey Grants Management Specialist NIH/NHGRI 5635 Fishers Lane, Ste 4076, MSC 9306 Bethesda, MD 20892-9306 Courier services should use: Rockville, MD 20852 Phone: 301-435-7859 Fax: 301-451-5434 Email: [email]